Leveraging existing HIV differentiated service delivery models to screen and treat hypertension in Ugandan persons living with HIV for dual control

PROJECT SUMMARY/ABSTRACT
The overall goal of the proposed Emerging Global Leader Award is to support Dr. Martin Muddu’s research
training to develop as an independent implementation science investigator in HIV and hypertension. Dr. Muddu
is a research scientist at the Infectious Diseases Research Collaboration (IDRC) in Kampala, Uganda. He
proposes to conduct an implementation science study to integrate HTN screening and treatment into
community-based, patient-centered models of HIV care known as “differentiated service delivery.”
Accomplishing the proposed study in this application will facilitate his training goals to: 1) gain mastery of
mixed methods implementation science research; 2) acquire expertise in design and analysis of quasi-
experimental studies; and 3) develop skills in leadership, grant and manuscript writing, and mentoring of junior
investigators. This proposal builds on the skills he already has in HIV and hypertension clinical medicine and
methods of observational studies. He will leverage an interdisciplinary team of mentors and advisors with
expertise in his area of study to become a productive independent researcher. Hypertension affects nearly
one-third of Ugandan PLHIV, a large proportion of whom are undiagnosed and untreated. The World Health
Organization HEARTS package is an evidence-based strategy for HTN management, which we propose to
adapt, integrate, and implement into community HIV differentiated service delivery models using rigorous
implementation science methods. This will form the integrated hypertension-HIV differentiated service delivery
model. We will then evaluate the implementation and effectiveness of the integrated hypertension-HIV
differentiated service delivery model regarding hypertension control in PLHIV. If implemented, this project will
generate evidence to inform guidelines for integration of HTN management into patient centered community
models of HIV care in Uganda and beyond.

Public health relevance
PROJECT NARRATIVE In Uganda, the prevalence of hypertension among adult persons living with HIV is 27.9% yet only 5% achieve control. Integrating screening and treatment of hypertension in HIV care is recommended by the World Health Organization (WHO) for dual control; however, there is limited implementation of this guideline. The goal of this project is to conduct an implementation science study to integrate hypertension screening and treatment into patient centered community HIV differentiated service delivery models in Uganda using the WHO HEARTS protocol to improve hypertension control in persons living with HIV